PREPLANNING FOR LATINO-FOCUSED HIV-AIDS RESEARCH

This project is being proposed in light of the continuing increase in reported AIDS cases among the Latino population of the United States. In the past two years the number of reported AIDS cases among Latinos has nearly doubled, going from 15,271 in June of 1989 to 29,586 in June of 1991. As HIV/AIDS continues to impact this population it is imperative that we develop a national AIDS research agenda to deal with this particular population. The goal of this project is to establish an organization and planning framework for the development of a national Latino focused HIV/AIDS research consortium. The objectives of this project are: 1) to begin to develop both national and regional networks of Latino AIDS researchers to facilitate networking, information sharing and research collaboration; 2) to identify potential institutions with the capabilities to implement the research activities of the consortium; and 3) to identify individuals to serve on a National Latino AIDS Advisory Committee to provide direction in planning the research consortium. To achieve these objectives the project will establish a Central Planning and Coordination office responsible for: 1) establishing an Executive Committee of Latino AIDS Researchers, 2) identifying institutions, 3) establishing regional linkages in areas with the highest concentration of Latino AIDS cases, 4) producing a national directory of Latino AIDS researchers, 5) hold regional meetings to establish regional networks of Latino AIDS researchers and to provide input on the development of a P20 planning grant proposal for Latino focused HIV/AIDS research.